Patient Experience of Specialty Care Coordination under the MISSION Act

Background. The MISSION Act incurs unprecedented challenges to care coordination due to greater use of
community care (CC). Yet VA lacks data on patients' experience of coordination, which hinders improvement
efforts. This prospective survey study focuses on VA primary care patients with common chronic medical
conditions that require care coordination [diabetes, congestive heart failure (CHF), and chronic obstructive
pulmonary disease (COPD)]. It will compare patients' experience of specialty care coordination with VA vs. CC,
examine how patients' and clinicians' experiences of coordination relate, and examine the association of
patients' experience of coordination to important outcomes.
Significance. This project addresses HSR&D priority: MISSION Act, coordination of VA and non-VA care. It
will examine how coordination, as experienced by Veterans, relates to both antecedents and outcomes in VA
and CC. These data are novel, important to VA's mission to ensure high quality care within VA and for CC, and
will be actionable by operational partners while advancing the science of care coordination.
Innovation. The surveys measure specialty care coordination directly, i.e. as experienced, by the three main
stakeholders (“triad”) in specialty care coordination: patient, PCP and specialist. Direct assessment of
coordination (rather than of satisfaction) provides specific, actionable information about what needs to improve.
The triad approach permits comprehensive assessment by those who most directly experience the effects of
efforts organize care. It also enables us to examine how stakeholder experiences inter-relate.
Specific Aims.
AIM 1. Compare patients' overall experience of coordination in VA vs. CC.
 H1a. Scores for overall coordination will be better in VA vs CC.
 H1b. The gap in coordination scores for high- vs. low-complexity patients will be less in VA vs. CC.
AIM 2. Examine how patients' overall experience of coordination correlates with those of PCPs and specialists.
 H2a. In VA, patients' scores for overall experience will correlate most strongly with scale scores for PCPs
and specialists on clarity and agreement on roles and responsibilities.
 H2b. In CC, patients' scores for overall experience will correlate most strongly with the scale scores for
PCPs and specialists that measure adequacy of data transfer.
AIM 3. Examine the association of patients' overall experience of coordination with selected outcomes: test
duplication, medication problems, A1C control (in diabetes), self-efficacy, and patient satisfaction.
 H3a. Each outcome is better in VA vs. CC.
 H3b. Better coordination as experienced by patients is associated with fewer duplicated tests and
medication problems, and better A1C control (in diabetes), self-efficacy, and patient satisfaction.
Methodology. VA primary care patients with referrals to VA or CC specialty care for diabetes, CHF, or COPD
will be included. Clinicians of patient survey respondents will be included. Surveys will be used to measure
coordination, medication problems, self-efficacy, and satisfaction. Test duplication and A1C control will be from
VA databases. Hierarchical regression models will control for the nesting of patients within facility complexity
levels, and system-level comparisons will account for selection bias with propensity score weighting.
Implementation/ Next Steps. Bi-annual reports for operational partners will include actionable and evidence-
based recommendations about clinical or policy interventions that could address any shortcomings we find. We
will apply for project funding to examine hypotheses generated by the proposed work. These may include
studies to examine, for example, best practices to coordinate from the patient and/or clinician perspective,
reasons for any observed facility effects, or prospective studies on coordination and other outcomes.

Public health relevance
Poorly coordinated healthcare increases patient and provider dissatisfaction, health risks, and resource waste. Coordination of specialty care is a particular challenge which is growing as Veterans receive more care from outside VA under the MISSION Act. To optimize specialty care coordination, we must account for the perspectives of Veteran patients. We will use surveys to compare VA primary care patients' experience of coordination for VA specialty care vs. community-based specialty care (CC); examine how clinicians' experience of coordination relates to that of their patients; and examine how patients' experience of coordination in VA and CC relates to test duplication, medication problems, A1C control (in diabetes), self- efficacy, and patient satisfaction. Results will be actionable by VA management, contribute to new scientific knowledge, and form the foundation of future work to better understand and coordinate specialty care, and ultimately improve satisfaction, health, and costs.